Synthesis of Antibiotics

My laboratory is working to develop new antibiotics for the treatment of infectious diseases in patients in the community and in hospitals. To do this researchers in my laboratory have devised the first practical laboratory synthetic route to the tetracycline antibiotics, which has enabled literally thousands of new antibiotic candidates to be prepared and evaluated for antibacterial activity, many of these with activity against strains resistant to tetracyclines and many other known antibiotics. In our research we seek to continue to develop innovative new chemistry that will make available many thousands more antibiotic candidates, substances that would be otherwise unavailable.

Public health relevance
The emergence of pathogenic bacteria resistant to many or all current antibiotics is a major public health concern. Research in my laboratory promises to provide thousands of new tetracycline antibiotics for evaluation as new clinical agents, offering a potential means to restock the supply of medicines for the treatment of bacterial diseases such as Staphylococcus, Streptococcus, Haemophilus, Acinetobacter, Klebsiella, Pseudomonas, as well as others.